A PHASE-I/II STUDY OF IMC-A12 IN CHILDREN WITH RELAPSED/ REFACTORY SOLID TUMORS"

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. This project will determine IGF-I receptor protein levels in PBMC's from patients before and after anti-IGF-I receptor protein levels in PBMC's from patients before and after anti-IGF-IR antibody therapy.